Contact-dependent transcriptional networks in mycobacterial species

In nature, bacteria live in communities that involve complex intercellular interactions that govern higher-­order processes such as biofilm formation, virulence and evolution. Communication between bacteria is important for the development, architecture and survival of these communities. Communication is generally mediated by secreted proteins, ligands and their surface receptors, which transmit the signals between, and into, cells. Nothing is known of intercellular signaling in mycobacteria, despite the likely importance of communication in coordinating communal activities in the environment, in biofilms and in infection. Our goal in this proposal is to address this gap in our knowledge and, thereby, begin to understand how and why mycobacteria communicate. Conjugal transfer of chromosomal DNA occurs from donor to recipient strains of Mycobacterium smegmatis by a distinctive process called distributive conjugal transfer (DCT). Utilizing RNA-­seq, we recently described transcriptional responses in donor and recipient cells that were contact dependent. Notably, this contact-­dependent signaling resulted in the induction and repression of many genes (>100) in both cell types, many of which are not associated with DNA transfer. Given the ubiquitous nature of cell-­cell communication in bacteria, we hypothesize that these non-­DCT transcriptional responses reflect other important forms of intercellular signaling and that this communication will be prevalent in co-­cultures of other mycobacterial species and between species. We will test this hypothesis by determining the co-­culture dependent, transcriptional responses of fast-­ and slow-­ growing mycobacteria, including M. abscessus and M. canettii (Aim 2). The signaling in M. smegmatis required the Type VII secretion system, ESX-­1, in the recipient strain and resulted in induction of the related esx4 secretion locus. Notably, esx4 was induced only in the recipient and its level of induction was responsive in trans to the ESX-­1 activity of the donor. These studies were the first to identify a biological role for ESX-­4, and importantly, showed that it is only expressed in response to cell-­cell contact. Our preliminary data show that the extra-­cytoplasmic sigma factor, SigM, is responsible for triggering esx4 expression. Moreover, the SigM regulon includes genes near esx4 that are also required for DCT, indicating that a functional esx4 locus extends beyond the recognized core locus. We will define the contact-­dependent SigM regulon that drives esx4 expression, which is required for DCT (Aim 1). This analysis will also serve to illustrate the power of our approach in first identifying and then characterizing other coculture-­dependent responses in mycobacterial communities.

Public health relevance
Project Narrative In nature, bacteria live in communities that involve complex cell- cell interactions that govern higher- order processes such as biofilm formation, virulence and evolution. Our published data have established contact- dependent communication between different isolates of Mycobacterium smegmatis that occur in biofilm- like conditions and involve specialized mycobacterial secretion systems. This proposal will determine the prevalence of cell- cell communication between other mycobacterial species and systematically identify the communication networks coordinating these interactions.